DEVELOPMENTAL GENETICS OF CAENORHABDITIS ELEGANS

The overall goal of this proposal is to elucidate the mechanisms of animal development through the study of the nematode Caenorhabditis elegans, a model organism chosen for its relative cellular simplicity and its advantages for classical and molecular genetic analysis. An understanding of the genetic basis of development may well be fundamental to much of medicine and may ultimately contribute important information to many problems, ranging from congenital defects to senescence. Five specific aims are proposed, as follows: Mutations in mec8-lead to defects in the function of three types of cells: body wall muscles, touch receptor neurons and chemosensory neurons. Molecular and genetic analysis indicates that mec-8 encodes a trans-acting regulator of the processing of pre-mRNA of various target genes, including unc-52 and mec-8 itself. The first aim is to characterize more fully the effect of mec-8 null mutations on the processing of the pre-mRNAs on the unc-52 and mec-8 genes and to characterize the cell-specific expression and function of mec-8. The second aim is to characterize genetically and molecularly two genes, called smu-1 and smu-2, which are defined by recessive mutant alleles that result in bypass suppression of all mec-8 mutant phenes. These genes may encode components of the pre-mRNA processing machinery. The third aim is to identify other loci that interact with mec-8. Recessive suppressors may identify genes that encode additional trans-acting pre-mRNA processing factors, and dominant suppressor of particular mc-8 phenes may identify targets of mec-8 action. Mutations that are synthetic lethal with mec-8 may identify genes whose functions overlap mec-8 function. Loss of function mutations in the lin-44 gene lead to reversals in the polarities of certain asymmetric cell divisions. lin-44 is a member of the Wnt gene family, which encodes secretory glycoproteins that act as intercellular signaling molecules. The fourth aim is to characterize the temporal and spatial appearance of lin-44 protein and to identify and characterize other loci whose products act in the lin-44 signal transduction pathway. The fifth aim is to conduct genetic mosaic analyses of developmentally- important genes. Emphasis will be given to high resolution mosaic analyses of recessive lethal mutations that are homozygous viable in at least one sizeable clone. The goal is to assess the functions of various essential genes in specific types of cells.